RIESSEARCH, LLC:1164941 [18-046091]

The purpose of this requisition is to support activities of the National Cancer Institute’s cancer surveillance program, notably the premier population-based cancer registry system, the Surveillance, Epidemiology and End Results (SEER) Program [http://seer.cancer.gov] managed by the Surveillance Research Program (SRP). Specific areas of activities and technical expertise relate to national and international Cancer Staging and Classification Systems.